Targeting the astrocyte-cerebrovasculature system to correct brain bioenergetics defects associated with APOE4

The Apolipoprotein E4 (APOE4) allele is the major genetic risk factor for Alzheimer's disease (AD), a
neurodegenerative condition marked by impairment of the brain bioenergetics. Energy dynamics in the brain are
tightly linked to neuronal activity and have a major impact on neuronal function. Glucose is the main source of
energy for the brain, and its cerebral fueling is guaranteed by glucose transporters within the brain vascular
system. Glucose is directly consumed by neurons or can be metabolized by astrocytes into lactate, which is then
exported to neurons as a supplementary energy source. When glucose supply to the brain from the blood is
insufficient, astrocytes can also generate fatty acid (FA) metabolites through mitochondrial fatty acid (FA) β-
oxidation (FAO) and these metabolites serve as alternative energy substrates for neurons. APOE4-mediated
disturbances of the FAO have been observed in cells at the blood brain barrier (BBB) and associated with
alterations in the BBB integrity suggesting that perturbations of the energy metabolism of these cells could lead
to deficits of neuronal energy supply in E4 carriers. Our previous work showed the AMP-activated protein kinase
(AMPK)-mediated acetyl-CoA carboxylase activation is affected in the cerebrovasculature of APOE4-TR and
E4FAD mice, with changes more pronounced in the presence of AD pathology in EFAD mice. As this system
plays a key role in linking glucose uptake and metabolism with FAO, we hypothesize that brain bioenergetics
deficits in E4 carriers, and more importantly in the presence of AD-related insults, result from a combination of
low glucose availability due to its poor transit across the BBB, particularly through the cerebrovasculature (CV),
and their reduced ability to switch towards compensatory mechanisms to meet brain bioenergetic needs. This
could be mediated by an inhibition of the GLP-1R-AMPK-ACC pathway in the E4-CV/astrocyte crosstalk system,
which would lower the FAO in these cells and alter their capacity to maintain
brain bioenergetic homeostasis.
Targeting the GLP-1R-AMPK-ACC pathway in E4 CV/astrocytes could serve as a promoter of the FAO to correct
the bioenergetics imbalance in E4 carriers. However, the impact of modulating this pathway in the CV and
astrocytes has not yet been fully investigated. Hence, using an AD mouse model, we will examine the influence
of different APOE genotypes on the GLP-1R-AMPK-ACC pathway in CV and astrocytes. We will also determine
whether treatments that induce activation of the GLP-1R-AMPK-ACC pathway could regulate FAO in E4 carriers,
which could open the door to new ways of treating AD. Thus, these proposed studies will provide critical insight
into the development of approaches for targeting brain bioenergetic pathways to prevent or reduce cognitive
decline in AD among high-risk APOE E4 carriers.

Public health relevance
The E4 allele of apolipoprotein E (APOE) is one of most important genetic risk factors for late onset Alzheimer’s disease (AD) and plays a central role in bioenergetic deficits and brain microvessel dysfunction associated with the disease. Although there is a clear association between the E4 allele and lower availability of glucose and fatty acids in the brain, the mechanism by which this allele leads to a reduction of energy substrates in the brain microvessels and consequently affects brain bioenergetics remains unknown. The proposed work will investigate the specific contribution of different microvessel's cells to E4-mediated energy deficits and will evaluate whether these changes act through the GLP-1R-AMPK-ACC pathway that could be used as a target for the development of therapeutic strategies specific to E4 carriers who are at high risk to develop AD.